Synaptic Homeostasis Modulated by Kv4

Kv4 channels have been shown to play important roles in modulating neural activity: regulating the
integration of high-frequency trains of synaptic input, regulating backpropagating action potentials, and
contributing to long-term potentiation. Consequently, mutations that affect Kv4 function/availability have been
shown to result in spatial learning defects, seizure behavior, as well as temporal lobe epilepsy. We have
recently shown that expression and turnover of Kv4 channels are also affected in three new contexts: in
modulating cholinergic synaptic homeostasis, in response to over-expression of human Aβ42, and during
normal aging. In the proposed studies, we investigate the mechanisms underlying Kv4 expression during
cholinergic synaptic homeostasis (also referred to as synaptic scaling). Synaptic homeostasis is a form of
plasticity that has been heavily studied in the last decade as a protective mechanism that counterbalances
changes in global neural activity; this likely occurs during physiological processes, such as learning/memory
and development, as well as during pathological conditions. We used Drosophila central neurons as a model,
and showed that Drosophila α7 (Dα7) nAChRs are up-regulated after cholinergic blockade, thereby enhancing
synaptic currents and providing a homeostatic response. We found that this homeostatic response triggered a
novel regulatory mechanism –the up-regulation of Kv4 channels, which we showed prevents an “overshoot” of
the homeostatic response. We further showed that the up-regulation of Kv4 channels is blocked by
transcriptional inhibitors, and is dependent on Dα7 nAChRs and Ca2+ influx. Drosophila continues to be an
ideal model system for these studies because of its cholinergic CNS, the genetic tools it offers, its less
redundant genome (eg. there is only a single Drosophila NFAT and Kv4 gene, each of which represents a
multi-gene family in mammals), and the ability to go from mechanisms of gene regulation to physiological
relevance in the intact brain, and whole animal behavior. The proposed studies will apply new optogenetic
approaches to elicit cholinergic synaptic homeostasis in vivo (Aim-1) –something that has not been explored in
any system, and which would currently not be feasible in mammalian systems. We will examine underlying
molecular mechanisms, including a novel relationship between α7 nAChRs and Kv4 channels (Aim-2), and
inactivity-induced transcription of Kv4 (Aim-3) that is mediated by NFAT (Aim-4). We will also test all molecular
mechanisms for their physiological relevance in identified neurons in the intact brain and behaving animal
(Aims 4-5). Our studies are likely to reveal novel insights into the underlying mechanisms of cholinergic
synaptic homeostasis.

Public health relevance
Kv4 channels have been shown to play important roles in modulating neural activity, and mutations that affect Kv4 function have been shown to result in spatial learning defects, seizure behavior, as well as temporal lobe epilepsy. Here, we investigate the mechanisms regulating Kv4 expression during cholinergic synaptic homeostasis, and the physiological consequences of this regulation. Synaptic homeostasis (also referred to as synaptic scaling) is a form of plasticity that has been heavily studied in the last decade as a protective mechanism that counterbalances changes in global neural activity. Although nearly all studies have focused on glutamatergic synapses, there is substantial evidence that cholinergic regions of the brain experience changes in neural activity in multiple pathophysiological conditions; for example, changes in the expression of nicotinic acetylcholine receptors (nAChRs) have been reported in patients and models of Alzheimer’s disease (AD), possibly providing initial protection from a faster decline in cognitive function, but eventually contributing to the progression of AD. Our studies seek insight into the underlying mechanisms of cholinergic synaptic homeostasis that may operate to protect the nervous system, but may also contribute to its dysfunction in particular disease states.